Addressing racial disparities in opioid overdose deaths using an open source peer recovery coach training and multimodal mobile health platform

Among people who use opioids (PWUO) some communities bear a disproportionate burden of
opioid-related overdose deaths. Health outcomes among PWUO may be worsened by multilevel
challenges, including lack of housing, social support, and patient education, which may be
partially addressed using scalable opensource solutions (e.g., peer recovery coaches, mobile
health, telemedicine). With NIH support, we have validated theory-based, artificial intelligence
(AI)-driven texting using natural language processing in a publicly-funded health system to
provide real-time responses to patient queries combined with automated texts to enhance
identification and address participant unmet social needs (e.g., access to peer support,
healthcare), and linkages and retention in buprenorphine treatment per the medical management
model (e.g., patient education, self-management). We have also refined an evidence-supported
Patient-Centered and Humility (PCH) training for peer recovery coaches (PRCs) that further
enhances efforts to address social needs while also including stigma reduction, health habitus,
and patient navigation to improve clinical outcomes and social services use among PWUO. This
proposal aims to adapt the evidence-supported PCH training to interactive video modules for
PRCs, and refine an AI-driven texting tool to reinforce core PCH principles. The 3-month pilot
RCT will test AI-driven PCH-enhanced texting tool + PCH-trained PRC providing telephonebased
services coordination (multimodal intervention arm-1) vs. AI-driven PCH-enhanced texting
tool (intervention arm-2) vs. treatment as usual / informational pamphlets only (control arm)
among emergency department enrolled PWUO (N=150) to estimate rates of PRC-PWUO contact,
AI-driven texting use among PWUO, assess potential for pre-/post-intervention impact on
reduction of felt and/or enacted stigma, clinical outcomes (i.e., time to initial receipt of
buprenorphine), and social services use at 1- and 3-months to obtain intervention effect sizes,
and estimate the associated cost of implementing and sustaining the multimodal intervention
(e.g., cost-per OUD treatment days). The RE-AIM framework will inform implementation of this
multimodal intervention that has high public health impact on complementing the HHS Overdose
Prevention Strategy (i.e., harm reduction, OUD treatment, and recovery support) in a manner that
is scalable and sustainable, and using open-source solutions. Our team is uniquely positioned to
obtain data that will inform a subsequent large-scale efficacy trial evaluating our proposed
multimodal intervention to increase access to buprenorphine and social services among PWUO.

Public health relevance
Among people who use opioids (PWUO) some communities bear a high burden of opioid-related overdose deaths. This proposal aims to adapt an evidence-supported Patient-Centered and Humility (PCH) training to interactive video modules for peer recovery coaches (PRCs) that goes beyond existing trainings for PRCs to also include health habitus, patient navigation, and patient education, and refine an artificial intelligence (AI)-driven texting tool to reinforce core PCH principles. The pilot RCT involves PRC completion of interactive video modules to facilitate telephone-based care coordination combined with AI-driven PCH-enhanced texting to deliver clinical and social services information to enhance receipt of buprenorphine among emergency department-recruited PWUO.